AHA Hypertension Scientific Sessions 2023

Project Summary
More than fifty percent of adults and children in the United States suffer from high arterial pressure
(hypertension). If untreated, hypertension can cause cardiovascular disease, kidney damage, and stroke. The
purpose of this application is to request travel funds to support trainees who wish to attend and participate in the
Hypertension Scientific Sessions 2023 to be held September 7–10, 2023 in Boston, Massachusetts.
Hypertension Scientific Sessions is the preeminent conference on hypertension, and it is organized by two
Councils of the American Heart Association: The Council on Hypertension and the Council on Kidney in
Cardiovascular Disease. This meeting is considered one of the most important and prestigious meetings focused
on hypertension. The conference includes oral and poster presentations selected from abstracts submitted by
clinical and basic researchers, followed by discussions facilitated by leading experts in their respective fields.
Attendees will have the opportunity to interact closely with experts from around the world involved in cross-
disciplinary research in hypertension, cardiac and kidney disease, genetics, stroke, and obesity. This meeting
will offer sessions specifically designed to benefit trainees and early career investigators. In addition, the meeting
offers Clinical Practice topics focused on applying clinical science and improving patient outcomes for primary
care providers. By supporting the travel, education, and development of promising early-career scientists, we
hope to expand and diversify the current workforce, thereby ultimately increasing the innovation of hypertension
research. The specific aims of 2023 Hypertension Scientific Sessions and this application are: 1) Provide early-
career attendees with a forum to present their research and obtain constructive feedback from a knowledgeable
international audience of scientists working in the field of hypertension; 2) Encourage trainees to enhance their
current knowledge by attending state-of-the-art and cutting-edge symposia and lectures organized by the
Planning Committee of the Hypertension Scientific Sessions; 3) Offer trainees an opportunity to network with
their peers and senior scientists in the area of hypertension; and 4) To increase the participation of speakers
and moderators from Historically Marginalized communities (HMCs). This award will multiply the participation of
researchers from HMCs, trainees, and early career scientists, in a welcoming environment devoted to learning
the latest advances in the field of hypertension at a time when institutions are still limiting expenditures on travel.

Public health relevance
Project Narrative More than fifty percent of adults and children in the United States suffer from have high arterial blood pressure (hypertension); if untreated, hypertension leads to cardiovascular and kidney disease and stroke. The purpose of this application is to request travel and caregiver funds to support trainees who wish to attend and participate in the Hypertension Scientific Sessions 2023 to be held in person on September 7–10, 2023 in Boston, Massachusetts. By supporting the travel, education, and development of these promising early-career scientists to this preeminent meeting, we hope to expand and diversify the current workforce, ultimately increasing innovation in hypertension research.